RANK Signaling Inhibitors for Osteolytic Lesions in Multiple Myeloma

Project Summary
Multiple myeloma patients often develop bone lesions, resulting in poor prognosis and skeletal-related events
(SREs, including hypercalcemia, spinal cord compression, vertebral collapse, pathologic fractures and bone
pain). Bone lesions in multiple myeloma patients are caused by increases in osteoclast formation activity. Hence,
antiresorptive drugs such as denosumab and bisphosphonates are presently used to treat bone lesions in
multiple myeloma. Nevertheless, both drugs cause osteonecrosis of the jaw by suppressing the immune system.
Denosumab is a human monoclonal antibody against RANKL, which is a critical regulator of osteoclast formation.
Moreover, denosumab increases risk of serious infections, which is due to the inhibitory effect of denosumab on
the immune system since RANKL also regulates immune cell development and survival. RANKL exerts these
diverse functions by activating its receptor RANK. Furthermore, as a biological agent, the cost of denosumab is
high and the method of delivery (injection) is not ideal. Thus, a better targeting strategy would be to use small
molecules to target RANK signaling pathways that are involved in osteoclastogenesis and multiple myeloma-
associated SREs but not in the immune system function. Our group previously discovered two motifs in the
RANK cytoplasmic domain that regulate osteoclast formation in vitro. To study the role of the two RANK motifs
in osteoclast formation in vivo, we have generated and characterized knockin (KI) mice bearing inactivating
mutations in the two motifs. Osteoclast formation is dramatically impaired in the KI mice, confirming the role of
these two motifs in osteoclast formation in vivo. Importantly, inactivation of these two motifs does not affect the
ability of RANK to mediate immune cell development and survival. Therefore, we hypothesize that specifically
targeting these two RANK motifs has the potential to serve as effective and selective therapeutic targets for bone
lesions in multiple myeloma. Our long-term goal is to develop efficacious and safe small molecule drugs targeting
the two RANK motifs for preventing bone lesions in multiple myeloma. We have developed cell-based assays
for identifying compounds targeting the two RANK motifs. From a high throughput screen of 200,000 compounds
with the cell-based assay systems followed by counter screen assays, numerous compounds were identified
that potently inhibited osteoclast formation. Medicinal chemistry efforts on two of these hit compounds has led
to the development of one compound that possesses improved potency and drug-like properties that are suitable
for proof-of-concept mouse model studies as well as back-up compounds. The objective of this R21 proposal
seeks to carry out important translational exploratory and developmental studies to evaluate the conceptual and
technical feasibilities of this novel therapeutic targeting strategy for bone lesions in multiple myeloma. Positive
outcomes of the proposed work will lay the solid foundation for applying for R01 funding to support future
development of efficacious and safe drugs for preventing and treating bone lesions in multiple myeloma patients.

Public health relevance
Project Narrative Patients with multiple myeloma have poor prognosis and frequently suffer from various skeletal-related events including life-threatening hypercalcemia, spinal cord compression, vertebral collapse, pathologic fractures and bone pain. This R21 proposal seeks to carry out translational exploratory and developmental studies to assess the conceptual and technical feasibilities of a novel therapeutic targeting strategy for preventing and treating skeletal-related events. Therefore, the proposed work is relevant to public health because positive outcomes from the proposed studies will lay the foundation for future development of efficacious and safe drugs for preventing and treating skeletal-related events in multiple myeloma patients.